Emergency Medicine Research Career Development Program in the Neurological Sciences (EMRCDP-NS)

The Emergency Medicine Research Career Development Program in the Neurological Sciences (EMRCDP-
NS) is a new national program that will recruit, mentor, train, and support early career emergency medicine
faculty across the country. This is important because emergency medicine physicians have unique access to
and experience with patients entering the emergency department with a variety of neurological disorders, yet
there is a dearth of emergency medicine physician-scientists due to the relative youth of the field. The program
will greatly expand the cadre of emergency medicine physician-scientists capable of performing NIH-funded
research focused on neurological disorders commonly treated in the pre-hospital and emergency department
settings. The EMRCDP-NS will be collaboratively led by a multi-PD team consisting of Robert Neumar, MD,
PhD (University of Michigan), Opeolu Adeoye, MD, MS (Washington University), Gail D’Onofrio, MD, MS (Yale
University), and Clifton Callaway, MD, PhD (University of Pittsburgh), as well as a 15-member National
Advisory Committee comprising renowned basic science, clinical, and health services investigators who have
strong records of research and mentorship. EMRCDP-NS scholars will be selected from a nationwide cohort of
highly qualified candidates within their first or second faculty year subsequent to completing emergency
medicine residency or fellowship training and who practice clinically at academic institutions that support
emergency medicine research. Candidate applications will follow the NIH K format. The program will accept 3
new scholars each year over a 5-year period (15 funded scholars total). In Phase I of the program, scholars will
receive up to 3 years of financial support from the EMRCDP-NS, including dedicated research time (75%
effort). Scholars will undertake their career development and research plan at their home institution with
support from a local mentorship team. They will also participate in the in-person EMRCDP-NS Annual Meeting,
in-person and virtual site visits, and bi-monthly virtual research training seminars. In Phase II (years 4-5) of the
program, scholars will ideally be supported by their own NIH or similar funding, and they will be required to
have at least 50% dedicated research time guaranteed by their home department to support their transition to
independence. To ensure a robust and diverse candidate pool, a Pipeline Program will be implemented with a
focus on diversity to prepare potential scholar candidates to submit competitive K12 applications. In addition,
promising applicants who are not selected for funding will be offered ongoing mentorship by program leaders
and will be encouraged to attend the Annual Meeting and virtual seminars. The primary goals of the program
are that all EMRCDP-NS scholars and many non-selected applicants obtain subsequent, individual major NIH
awards (e.g., NIH K or R01-equivalent), have sustained careers of NIH-funded research, and mentor the next
generation of emergency medicine physician-scientists. Moreover, the EMRCDP-NS program will help build a
culture of research excellence in the specialty of emergency medicine that will positively impact the field.

Public health relevance
PROJECT NARRATIVE There are more than 130 million emergency department visits in the U.S. each year, and many emergencies involve injuries and illnesses related to the brain, including stroke, seizures, traumatic brain injury, spinal cord injury, pain, addiction, and neurodegenerative diseases. To help advance research in these areas, this national Emergency Medicine Research Career Development Program in the Neurological Sciences (EMRCDP-NS) aims to increase the number of emergency medicine clinician-scientists conducting successful and transformative research on neurologic (i.e., brain) disorders. To achieve this, we will identify, recruit, and support promising emergency medicine researchers at the beginning of their careers and ensure they have the time, mentorship, and training needed to effectively perform research that can improve the care of patients with neurologic disorders in the emergency department.